Sample Preparation and Screening of Non-invasive Pediatric Specimens for Lower Respiratory Disease

To expand the capabilities of current technologies to process non-invasive clinical samples for rapid diagnosis of respiratory infections in children.